THE COVID 19 SERVICES CATALYZE TRANSLATIONAL RESEARCH FINDINGS INTO PUBLIC HEALTH CHANGES TO ADDRESS THE NOVEL CORONAVIRUS PANDEMIC THROUGH IMPLEMENTA

Advanced BioScience Laboratories, Inc. (ABL) is a global contract manufacturing organization with experience in biologics R&D, scale-up, and production following current Good Manufacturing Practices (cGMP). ABL partners with our clients to support GMP manufacturing needs. Dr. Wlodawer, Chief of the Macromolecular Crystallography Laboratory with the NCI-Frederick is working on a project, Chimeric ACE2 Peptide Ligand for Diagnostic Assays of SARS-CoV-2, under the Intramural Targeted Anti-Covid19 (ITAC) Program, which provides supplementary support for COVID-19 research activities for intramural investigators